The role of the intracellular complement system - the complosome - in Th1 biology

We have relocated in February 2017 to the NIH. By now, the laboratory is up and running and we have made substantial progress in the aims set for this year: A. Regulation of C3 and C5 gene expression: The controlled regulation of C3 and/or C5 gene expression ideally from the cell surface - would be an additional means to manipulate Th1 responses at will. In collaboration with Steve Holland (NIAID, NIH) and Adrian Hayday (KCL), we have identified the integrin LFA-1 as a master regulator of C3 gene expression in a range of immune cells and are currently assessing the in vivo significance and druggability of this novel integrin/complement crosstalk. B. Direct regulation of IL-10 production: We have identified a receptor that, when activated, completely abrogates IL-10 switching in Th1 cells.We are currently assessing the signaling pathway driven by this receptor that leads to the loss of IL-10 production in CD4+ T cells.